Contextual modulation of visual decision-making across the visual hierarchy

Project Summary/Abstract
In sensory decision-making, choices are influenced by non-sensory factors such as
motivation, attention, and recent trial history. We seek to incorporate these influences into a
drift diffusion model (DDM), by modeling non-sensory variables as deterministic modulators of
the starting point or drift rate of sensory evidence accumulation. However, decision-making
models are subject to confounds due to the non-stationarity and correlations in long-term
behavioral data. More work is needed to quantify these properties and develop new statistical
approaches to overcome them. Existing datasets have proven inadequate, so new datasets
must be collected. To gain insight into the neural mechanisms of contextual modulation in
decision-making, our goal is to compare non-sensory influences on sensory decision-
making across levels of the visual hierarchy and between parallel visual streams. We
have evidence there are differences, which could be leveraged to identify where in the brain
non-visual information enters into visual decision-making. To establish feasibility for an R01, we
need to establish a new collaboration with a statistician, develop methods for training
single animals in multiple visual tasks; show that visual tasks differ in their sensitivity to non-
sensory modulation; and show that we can obtain the amount of trial data required to fit and
compare models within subject. We propose to train individual animals in grating orientation,
random-dot motion, object identity, spatial location of luminance or contrast, as well as piloting
two new tasks (stochastic drifting grating, spatial location of motion). These visual features are
thought to be extracted in different brain areas: in primary visual cortex (V1); in different higher
visual areas (HVAs) in ventral or dorsal streams; or in a V1-independent collicular pathway. We
will collect long-term data on the interleaved tasks using automated high-throughput in-cage
testing, and validate that these data meet statistical requirements for model fitting. Rats are
ideal for this study because individual rats can learn multiple visual tasks, and we are able to
obtain 105-106 behavioral trials per rat without water or food restriction. Rats are also suitable for
viral vector targeting strategies and high-density electrophysiology with optogenetics in freely
behaving animals. At the end of this 2-year R34 project, the lab will have assembled a new
multi-disciplinary research team poised for dissection of underlying circuit mechanisms, with
validated visual tasks, training protocols, statistical approaches, and model-fitting methods.
These preparations will support a BRAIN Initiative: Targeted BCP R01 application aimed at
dissecting neural representations and circuit mechanisms of contextual modulation of choice.

Public health relevance
Project Narrative A lot of our basic knowledge about decision-making comes from studying decisions about visually ambiguous cues. Non-visual factors such as attention, motivation, and history, can bias how animals and people decide what they have just seen. Since different kind of visual cues (like motion versus shape) are detected in different parts of the brain, comparing decisions about them could help us discover where, how and why these biases arise in the brain.